Pediatric Injury Research Training Program

Project Summary:
This is a proposal for the renewal of our Pediatric Injury Research Training Program. Our goal is to create and
sustain a corps of interdisciplinary-trained investigators who will conduct rigorous research on ways to reduce
the toll from injuries. This application and our training program uniquely address pediatric injury and
proposes an innovative partnership with the University of Washington Center for Indigenous Health. Our
goal is to both increase the number of indigenous injury research investigators and to expand the
research on injuries among native children and youth. The specific aims of this training program are to: (1)
Recruit and train 3 outstanding post-doctoral fellows annually for a two year program from a national
applicant pool with attention to diversity in clinical and academic backgrounds, socioeconomic status, race,
ethnicity and gender, and specific recruitment of indigenous post-doctoral fellows. (2) Educate fellows with
state of the art and well balanced curricula in injury control and theory along with methodological skills
in research, including community-based participatory research (especially for individuals who have typically
not been trained in injury research) and an introduction to non-clinical disciplines important to interdisciplinary
research. (3) Provide an enriched learning environment with highly engaged mentors who provide practical
and relevant research experience and serve as role models for trainees as teachers, researchers, and clinicians,
and who assist trainees with placement beyond the trainee program to support continued career development
as investigators. To accomplish this, there are 4 training components: 1. Formal didactic courses to fill gaps
in prior academic training to conduct research in injury control and to provide exposure to disciplines relevant to
injury research. These have been adjusted this year to better meet the needs of our fellows, and to include
deeper education on health disparities and equity. 2. Attendance at fellowship-focused seminars including
weekly small group research seminars, a 12-week Biomedical Integrity in Research Seminar Series, formal
training in scientific writing, and grant writing. 3. In depth research training in an active, on-going research
program at one of the training units with mentoring from an interdisciplinary group of faculty at the UW and its
collaborating sites. 4. Development and implementation of research projects in injury research, supervised by
one or more of the core faculty mentors, to achieve the following goals: (1) To develop the research skills
necessary to initiate a career as an independent investigator in injury control research. (2) To become expert in
a focused area of pediatric injury control research and begin to develop a trajectory of research on which to build
a successful career as an extramurally funded investigator. (3) Become competent in conducting culturally
appropriate and competent research.This application and our training program uniquely address pediatric
injury (scientific focus) and it remains the only comprehensive interdisciplinary pediatric injury research
training program in the nation that addresses injury and violence of all types.

Public health relevance
Project Narrative Injury control is directly related to the mission of NICHD and to key overarching goals of Healthy People 2030. Continued attention to controlling injuries in children and reducing health disparities and inequities related to injury remains a foremost challenge for public health. This Pediatric Injury Research Training program remains the only comprehensive pediatric injury research training program in the nation that addresses injury and violence of all types, and with a new focus on reducing health disparities and training indigenous researchers.